CANCER CENTER SUPPORT

The University of Wisconsin Clinical Cancer Center is a multidisciplinary, interdepartmental organization that facilitates high quality clinical and laboratory research training and cancer care. The Center Faculty, utilizing Center space and facilities, excels in laboratory and clinical research exploring cancer problems. Through its investigation of human cancer, it serves residents of Wisconsin and adjoining areas of Iowa and Illinois by providing optimal cancer care and innovative clinical trials. The Center offers unique opportunities to train cancer specialists in laboratory, clinical and statistical disciplines. Its outreach programs involve other cancer care and research institutions in the state as well as the public and professionals in the area. The Cancer Center Sup;port Grant to the UW Clinical Cancer Center aids in progressing towards the long term goal, reduction of the incidence, mortality and morbidity of human cancer. The broad objectives of the center are: 1. To undertake innovative laboratory and clinical research probing biologic problems in cancer. 2. To facilitate clinical applications of findings from research. 3. To improve cancer care through clinical trials. 4. To train specialists in cancer related fields. 5. To educate students, professionals and the public in Wisconsin about cancer.